Administrative Core

PROJECT SUMMARY
The Administrative Core maintains the organizational structure necessary to provide the scientific and
budgetary oversight described in all sections of the Utah Center for Iron and Heme Disorders (CIHD). The
administrative core will maintain all communications within the different components of the CIHD, the 4
scientific cores, the enrichment program and work with the Operational Committee to maintain budgetary
oversight and programmatic goals. The communications between the Executive Advisory Committee will also
be a specific responsibility of the Administrative Core. All of this activity can be provided to the External Expert
Panel (EEP) on request. The Administrative Core is to provide guidance and oversight for maintaining
appropriate billing structures within each of the scientific cores and to ensure that funds are spent according to
University and NIH programmatic guidelines. While not a required component of the CIHD, we feel that our
Pilot and Feasibility Program (P&F) has been successful in drawing new people to the field and we propose to
continue the P&F on a limited scale. The Enrichment Program is also administratively managed to support
financial aspects important to ensure that P&F awardees present their findings in concert with other events
supported by the CIHD. The management of web content to provide electronic access to projects funded and
services, protocols and important additions to the cores is managed through this group. Membership to the
CIHD is coordinated through the Admin Core, from initial application through Executive Committee voting and
feed back to applicants. The Administrative Core is led by Dr. John Phillips, with assistance from seasoned
members of our CIHD, Drs. James Cox, Diane Ward and Dennis Winge. Together, this group works with staff
to manage events, meetings, the website and Enrichment activities.